Stalled capillary flow: a novel mechanism for hypoperfusion in Alzheimer disease

Summary
This grant focuses on understanding the causes and consequences of cerebral blood flow decreases in mouse
models of Alzheimer’s disease (AD). We recently showed there is increased incidence of the transient arrest of
circulating neutrophils in capillaries in the brain of AD mouse models. Because blood cells flow single file in
capillaries, this leads to stalled flow in the capillary segment. We serendipitously discovered that administration
of antibodies against the murine neutrophil surface protein, Ly6G, rapidly interferes with this neutrophil arrest,
decreasing the incidence of stalled capillaries by about two-thirds. We further found that this decrease in capillary
stalling was associated with a ~30% increase in cerebral blood flow, and was accompanied by a rapid
improvement (within hours) in performance on spatial and working memory tasks. In this grant, we are aiming
to:
• Aim 1 – understand the cellular mechanisms contributing to neutrophil arrest in capillary segments, where
we test three hypotheses: capillary constrictions caused by pericytes; binding to increased adhesion
molecules on the endothelial surface; binding to exposed basement membrane and adhesion molecules
in the widened gap between endothelial cells.
• Aim 2 – evaluate the role of reactive oxygen species produced by NAPDH oxidase as an initiating factor
in the arrest of neutrophils in capillaries.
• Aim 3 – assess whether improving cerebral blood flow over time decrease amyloid-beta aggregation and
neuropathology, taking advantage of knock-in mouse models of AD.
• Aim 4 – use three photon excited fluorescence microscopy to assess capillary stalling and blood flow in
the hippocampus
We have made major progress on Aims 1 and 2, with a recent publication and a second manuscript currently in
revision. We are conducting experiments for Aim 3 now, and we had our first hippocampal imaging working in
the last couple of months to start Aim 4. Unfortunately, we had a ~15 year old femtosecond laser system recently
fail. This laser is essential for the two-photon excited fluorescence microscopy that is the dominant experimental
approach we use in this work. We are requesting supplemental funding to help replace this laser.

Public health relevance
Project Narrative There is no treatment to correct the reduced brain blood flow observed in Alzheimer disease patients, although this reduction likely contributes to cognitive deficits and may accelerate disease progression. We recently found that blood flow in individual brain capillaries is stalled by arrested white blood cells in mouse models of Alzheimer’s disease, and we now propose to investigate the molecular and cellular mechanisms causing these capillary stalls and to determine the impact of increasing brain blood flow by interfering with capillary stalling on the progression of disease. These capillary stalls are a potential mechanism for the decreased blood flow in AD, and this work could lead to novel therapies that improve cognitive function and slow Alzheimer’s disease progression.